Notch2 Amplification of B Cell Division and Differentiation Fates

Project Summary
The cellular and molecular mechanisms controlling cell cycle entry and plasma cell differentiation remain poorly
understood. One key facet to this problem is how naïve B cells achieve a state of readiness for the plasma cell
(PC) fate. This project strives to understand the molecular mechanisms whereby activation of the Notch pathway
in naïve B cells fosters biochemical events that accelerate both mitosis and PC differentiation. Further, this
project addresses whether these processes will amplify B cell responses to SARS-CoV-2 immunogens. One
major hurdle to vaccine development for complex pathogens are facilitating diverse and durable antibody
responses that can keep up with rapid mutations and stand the test of time. As such, understanding the
mechanisms that underlie optimal B cell responses are vital to improve vaccine design. One distinctive B cell
subset, marginal zone (MZ) B cells, exhibit a selective advantage at generating effector responses. Residing in
the marginal sinus of the spleen at the interface between incoming blood supply and lymphoid follicles, this
innate-like subset responds to blood-borne antigens, serving as a first line of defense to generate antibody-
secreting PCs in a matter of hours. Unlike conventional follicular (FO) B cells, MZ B cells have a distinctive
requirement for the signal Notch2, an evolutionarily conserved transmembrane receptor family member that
dictates cell fate decisions. Notch2 is known to drive lineage commitment of the MZ B cell pool during
development, but how this signal is used continuously to maintain mature MZ B cells is poorly understood. As
such, it is reasonable to speculate that Notch2 signaling instructs a constitutively poised state in resting B cells
by modifying activation requirements and differentiative events. Indeed, preliminary data demonstrate the
induction of Notch2 signaling in non-poised FO B cells enhances their responsiveness to antigen receptor or
TLR signals to promote their proliferation and differentiation into PCs. The central hypothesis of this proposal is
that Notch2 independently augments PC differentiation and cell division, both features which hold potential to
amplify vaccine responses. Herein, this proposal will independently interrogate the mechanism(s) by which
Notch2 modifies proliferative and differentiative potentials in aim 1, and the potential for Notch2 signals to
improve SARS-CoV-2 vaccine responses in aim 2. The significance of investigating how Notch2 regulates B
cell responses is twofold. For one, this proposal will challenge the current understanding of Notch2 as a
determinant of cell fate decisions, elucidating how this signal is tied to activation and effector programs.
Additionally, this proposal can better inform vaccination strategies using Notch2 signaling as a tool to enhance
the frequency and diversity of a given antibody response.

Public health relevance
Project Narrative Notch2 is a key signal responsible for the development and maintenance of functionally poised marginal zone B (MZ B) cells, but whether Notch2 engenders these efficient effector programs in MZ B cells is not well understood. This proposal will investigate the mechanisms that amplify mitotic and plasma cell (PC) responses in Notch2-experienced cells and apply them in a DNA vaccine setting for SARS-CoV-2 receptor binding domain (RBD). These findings will elucidate strategies to augment B cell responses in sub-optimal vaccine settings.